OPEN LABEL STUDY OF GABAPENTIN AS MONOTHERAPY IN TREATMENT OF EPILEPTIC SEIZURE

The purpose of this study is to obtain information on the long term safety and tolerance of Gabapentin when used alone or in combination with other possible elements; and, to evaluate the effectiveness of Gabapentin in preventing seizures.